Mechanisms of mitochondrial mutation rate variation across eukaryotes

PROJECT SUMMARY
This administrative supplement will be used to replace broken equipment (an Agilent TapeStation) that is
essential to the project funded by the parent award on mechanisms of mitochondrial mutation rate variation.
The project relies on generation of specialized high-throughput DNA sequencing libraries with ultra-high fidelity
to detect de novo mutations. These libraries must go through a quality control process, which includes analysis
of size distribution and quantity with a TapeStation. The requested TapeStation 4150 unit will replace a
TapeStation 2200 unit that is no longer operational and cannot be repaired because the manufacturer no
longer supports the outdated model. The replacement will be used to complete project goals over the 3+ years
remaining on the parent award.

Public health relevance
PROJECT NARRATIVE This administrative supplement will be used to replace a TapeStation instrument that broke down and cannot be repaired because it is an older model that is no longer supported by the vendor. The replacement instrument will be used for performing quality control on DNA sequencing libraries, which are an essential part of the project funded by the parent award on mechanisms of mitochondrial mutation rate variation.